Multi-organ-on-chip device for modeling opioid reinforcement and withdrawal, and the negative affective component of pain: a therapeutic screening tool.

Abstract
The significance of the public health crisis presented by the epidemic in opioid abuse is abundantly clear.
There is a desperate need to develop therapeutics for treatment of opioid use disorder (OUD), and also to
develop pain treatments that are non-addictive. Both of these goals will be served by high-throughput models
amenable to drug screening, based on the use of human cells, that recapitulate features of the neurobiology
underlying the addictive process. The model we propose to develop focuses on a key component of addictive
circuitry – the dopaminergic and Gamma-Amino Butyric Acid (GABA)ergic neurons of the midbrain, long
recognized as responsible for mediating the reinforcing properties of many classes of abused drugs, including
opioids. We will develop multi-organ, microphysiological systems (MPSs) based on the use of human induced
pluripotent stem cell (iPSC)-derived midbrain-fated dopamine (DA)/ GABA neurons on a three-dimensional
platform that incorporates microglia, blood-brain-barrier (BBB) and liver metabolism components. RNA
sequencing (RNAseq) and metabolomics analyses will complement the primary DA release measure to identify
novel mechanisms contributing to chronic opioid-induced plasticity in DA responsiveness thought to underlie 1)
the anhedonia characteristic of opioid withdrawal; 2) the negative affective component of chronic pain states;
3) craving and relapse. The chronic pain-relevant aspect of the model will be realized by examination of
aversive kappa-mediated opioid effects on DA transmission in addition to the commonly abused mu opioid
receptor agonists, and by incorporation of inflammatory-mediating microglia into the model. The incorporation
of BBB and liver metabolism modules into the MPS platform will permit screening of drugs in the UH3 phase of
the project that accounts for different routes of abused opioid administration and the bioavailability of potential
therapeutic drugs, increasing translatability. Throughput will be increased by the integration of online sensors
into the MPS for online detection of DA and other key analytes identified in the UG3 phase of the project. For
addiction-treatment screening we will use a curated set of 100 chemical genomics probes from our UCLA
kinase inhibitor library. The focus on kinases is based on their well-described role in plasticity, and will cover
activities along the BDNF signaling pathway, mTORC2, mTORC1, AKT and other targets along the BDNF axis.
Our selection of compounds/targets in this context will also be informed by the RNAseq and metabolomics
results from the UG3 phase and we will supplement other drugs if needed from UCLA’s Molecular Screening
Shared Resource chemical genomics libraries, which is over 3k probes strong. Although not proposed here, it
is also important to point out that the MoC device could also be used to test the abuse liability of novel
antinociceptive agents identified by other screening tools. With an interdisciplinary team of scientists and
engineers, this proposal will build upon recent advances in organ-on-a-chip and iPSC technologies to create
innovative MPSs with high potential to have significant clinical impacts in the future.

Public health relevance
Project Narrative The addictive quality of opioid drugs is known to involve changes in the activity of neurons in the brain that utilize dopamine as a neurotransmitter. The search for drugs that can reverse such changes and potentially treat addiction to opioid drugs, as well as the search for analgesics that are devoid of addictive qualities, will be aided by model systems based on human cells. We aim to design such “organ-on-chip” model systems and use them to better understand the addictive process at a molecular level and to potentially identify new therapeutics to treat drug addiction and chronic pain.